COMPARISON OF SIMPLY EGGS &SHELL EGGS IN DIET TO DETERMINE BLOOD CHOLESTEROL

Examine the effects of whole eggs (WE) and the reduced cholesterol egg product Simply Eggs (SE) on blood cholesterol levels of healthy men and women.